Orbitrap ID-X Tribrid Mass Spectrometer for Unbiased Global Metabolomics Profiling

ABSTRACT
The goal of this S10 application is to request funding for a high resolution Orbitrap ID-X Tribrid mass
spectrometer (OT IDX) to enable identification and quantification of global metabolite profiles in various
biospecimens. This will fill a “missing link” in the Metabolomics Core at Baylor College of Medicine that has to
date, excelled in offering targeted metabolic profiling platforms to support scientific investigations. OT IDX will
be used to develop robust and well tested methods for profiling steady state levels of metabolites in a global
fashion as well as changes in metabolic flux in a global scale. These technologies that will be offered as a new
line of service in the Metabolomics Core will support studies using pre-clinical specimens (cell line-derived
xenografts, patient-derived xenografts and transgenic models), clinical specimens and cell lines. Importantly, the
unbiased technologies will support projects in the areas of Cancer, Diabetes, Obesity, Environmental Exposures,
Viral infections, etc. The OT IDX will be administered by the Baylor Metabolomics Core under the Advanced
Technology Core Umbrella. The installation, and implementation of OT IDX will be significantly supported by the
institutional funding that will cover personnel, Service Contract, software and training costs. The functioning and
output of the OT IDX will be monitored by the Internal Advisory Committee and External Advisory Committee,
which have experts in metabolomics, Core leaders and institutional representatives. Based on the outstanding
track record of the Metabolomics Core at Baylor College of Medicine, the Core is strongly positioned to establish
the innovative unbiased global metabolic platform using OT IDX in the institution. This will allow investigators to
develop novel hypothesis and leads that could culminate in new biomarkers and novel therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Metabolomics Core at Baylor College of Medicine (BCM) supports targeted metabolomics and unbiased lipidomics studies within the Institution and in the Texas Medical Center. Implementation of an unbiased metabolic profiling platform to measure global changes in steady state levels of metabolites and metabolic fluxes is a “missing gap”. This is more so in the context of the new institutional strategic vision to enhance translational science and build strength in the area of precision medicine. This S10 application proposes to fill the gap by developing and implementing an unbiased global metabolic profiling platform on the Orbitrap ID-X Tribrid Mass Spectrometer.